Long-Term Consequences of Acute Organophosphate Intoxication in an Adolescent Rodent Model

Acute organophosphate (OP) intoxication, resulting from chemical warfare, industrial accidents, and intentional
exposures, remains a significant global health crisis, leading to substantial morbidity and mortality. Survivors can
quickly develop status epilepticus (SE), which may progress to spontaneous recurrent seizures (SRS), cognitive
impairments, and chronic neurological dysfunction. Current standard of care (SOC) treatments, including
atropine, pralidoxime (2-PAM), and midazolam (MDZ), improve acute survival but often fail to prevent SE
progression, the onset of SRS, and long-term impairments. This is especially concerning during adolescence, a
critical period of neurodevelopment and evolving seizure susceptibility, yet little is known about how OP
intoxication and SOC treatments, including MDZ, affect disease progression. Additionally, while prolonged
acetylcholinesterase (AChE) inhibition has been linked to elevated seizure burden in adult models, its recovery
trajectory during adolescence remains poorly understood, along with its relationship to seizure development,
benzodiazepine efficacy, and cognitive deficits. To address these gaps, we propose a first-of-its-kind longitudinal
study investigating acute OP intoxication in adolescent rats (postnatal day 35) using clinically relevant outcome
measures. This study will systematically assess the natural history of seizure development, changes to neural
oscillatory activity, and cognitive function over an eight-week period following acute diisopropylfluorophosphate
(DFP) intoxication, while also evaluating the effects of SOC with and without MDZ. In parallel, we will track AChE
suppression and its recovery profile to determine its relationship with SRS development and learning and
memory impairments. We hypothesize that DFP intoxication during this developmental period will result in SE,
the emergence of SRS, persistent disruptions to network oscillations, and cognitive deficits. Furthermore, we
expect that while MDZ treatment will mitigate SE-related mortality, it will have minimal impact on the long-term
trajectory of disease progression. Finally, we anticipate that AChE recovery will be prolonged during
adolescence, with delayed restoration correlating with greater seizure susceptibility and cognitive deficits,
revealing a critical mechanistic link between cholinergic dysfunction and behavioral alterations. This study will
establish the first comprehensive model of acute OP intoxication during adolescence, providing key insights into
age-dependent vulnerability, treatment efficacy, and long-term sequelae. By aligning this model with previously
established adult paradigms, these findings will directly inform more effective treatment strategies, guiding the
identification of targeted countermeasures that consider both age and sex as key variables.

Public health relevance
Acute organophosphate (OP) intoxication is a critical public health concern, as it can result in status epilepticus, spontaneous seizures, and lasting neurological dysfunction. This study will investigate the natural history of seizure development, changes to neural oscillations, cognitive impairments, and acetylcholinesterase recovery following acute diisopropylfluorophosphate intoxication in adolescent rats, while also evaluating the effects of current standard of care treatments, including midazolam. By evaluating translationally relevant outcome measures, including neural activity, behavioral function, and cholinergic dynamics, our findings will address critical gaps in adolescent OP research, leading to the identification of more effective countermeasures that account for both age and sex as biological variables.